Core A, pp. 67-75

PROJECT SUMMARY (See instructions): The goal of the administrative Core is to ensure efficient management of the program project grant. The Core will support the general operations of the grant. The Core operations will be carried out by a lab manager who will interact with the PI and with the Administrations of our Department and Harvard Medical School. The lab manager will interact with the leaders and personnel of the research components and the other Cores. The Core will carry out financial operations, purchasing, allocation of resources, instrument time, organization of meetings between key scientist, prepare progress reports. It will be responsible for space management, travel arrangements. It will assist new laboratory members with getting integrated in the groups. It will be involved in managing laboratory information managing system.

Public health relevance
The Administrative Core is essential for a smooth overall operation of the program project grant.